Development Funds

Developmental funds have played an important role in the development of the Cancer Center, particularly in recruiting new investigators and in establishing new Shared Resources. During the current funding period developmental funds were instrumental in the recruitment of three new investigators and in the development of two new Shared Resources (Advanced Biophotonics and Gene Transfer, Targeting and Therapeutics/Viral Vectors). We propose to continue our recruitment efforts to strengthen the scientific programs of the Cancer Center

Public health relevance
RELEVANCE (See Instructions): The research mission of the Cancer Center is to understand the fundamental aspects of biology related to cancer. Developmental funds will provide support for new investigators, enable the exploration of new research directions, new collaborations and support the translation of basic research into therapies for cancer.